From traditional medicine to innovation: Discovering novel analgesics targeting calcium modulation from Cameroonian phytochemicals

PROJECT SUMMARY/ABSTRACT
There is a pressing need to identify and validate new targets for chronic pain and new sources for novel
compounds. This proposal will use novel extracts and pure compounds from multiple Cameroonian plants
namely Paullinia pinnata, Petersianthus macrocarpus and Acacia sieberiana to probe the biology and therapeutic
potential of an exciting non-opioid target for pain, focusing on calcium homeostasis especially through sigma 2
(σ-2) (aka transmembrane protein 97 (TMEM97)). “Agonists” for σ-2/TMEM97 reduce neuropathic and
inflammatory pain in mice. Our primary research goal is to use a focused interdisciplinary approach to isolate
bioactive compounds from traditional medicine and utilize these new tools in Cameroon to address research and
education disparities that contribute to poor pain outcomes in Central Africa. This goal will be pursued with a
unique collaboration that we have developed between researchers at the University of Dschang (Cameroon; Dr.
Nguelefack), the University of Texas at Dallas (USA; Dr. Kolber) and the University of Kentucky (USA; Dr.
Tidgewell). Preliminarily, the Nguelefack lab has shown that crude extracts of P. Pinnata, P. macrocarpus and
A. sieberiana significantly decrease inflammatory and neuropathic pain in rats. The Tidgewell/Kolber groups
have shown that the methanol extracts of P. pinnata show in vitro binding affinity to σ-2/TMEM97 and modulate
primary sensory neurons. This proposal will utilize our interdisciplinary and international approach with in vitro
evaluation of plant extracts, followed by fractionation, in vitro testing of σ-2/TMEM97 binding, and additional in
vitro validation at UT Dallas and Dschang with pure compounds. In addition to the research focus on Ca2+
homeostasis, this proposal aims to build research and clinical capacity for the study of pain in Cameroon and
surrounding countries. This will be accomplished using a mixture of capacity building initiatives including the
training of Cameroon trainees in the US and Cameroon, the building of Dschang University as a center for pain
research in central Africa, and the hosting of local workshops at Dschang to support the spread of research
knowledge in Cameroon and surrounding countries.

Public health relevance
PROJECT NARRATIVE Chronic pain is a serious problem in the USA and worldwide and this international collaboration focuses on the use of interdisciplinary approaches to identify and validate novel drug targets and build pain research capacity in Cameroon and Central Africa. The scientific focus of the proposal is on identifying the compounds from analgesic medicinal plants that modulate neurons through calcium metabolism. This includes investigating Cameroonian plants used in traditional medicine, like Paullinia pinnata, that show analgesic effects in models of pain, have affinity for the calcium modulator sigma-2 (σ-2)/Transmembrane Protein 97 (TMEM97) receptor in vitro, and are capable of regulating primary sensory neurons.